Weill Cornell Initiative for Maximizing Student Development

PROJECT SUMMARY/ABSTRACT
The Weill Cornell Graduate School (WCGS)—an educational and training partnership between Weill Cornell
Medicine and Memorial Sloan Kettering Cancer Center—is a premier institution for PhD training in the
biomedical sciences. We look to leverage our training capacity to increase our rates of attracting, retaining, and
developing doctoral students historically underrepresented in science (URiS) as leaders in the biomedical
workforce. To accomplish this goal, we propose a Weill Cornell IMSD program with the following objectives: (1)
Attract a pool of well-prepared URiS students to WCGS; (2) Build a robust, self-renewing community of URiS
doctoral students through an early start program, multifaceted mentorship, and social gatherings; and (3) Equip
IMSD scholars with leadership training, professional skills and networks to be leaders in a variety of biomedical
and science-related careers. WCGS is primed for training the next generation of URiS biomedical scientists
and we are confident that through the Weill Cornell IMSD, we can develop a steady stream of well-trained
PhD’s that will both diversify and bring innovation to the biomedical workforce.

Public health relevance
PROJECT NARRATIVE The Weill Cornell Initiative for Maximizing Student Development (Weill Cornell IMSD) will increase the number of underrepresented doctoral students who are trained to conduct exceptional research and continue as leaders in biomedical research careers. By helping to diversify the biomedical workforce, the Weill Cornell IMSD will take part in addressing the critical need to reduce racial and ethnic healthcare disparities.